Unlocking Biologically-Relevant Opportunities Through Applications of Excited-State Aromaticity and Antiaromaticity

Project Summary
A current research interest of my group is to develop conceptual models to explain, to understand, and to
predict structure and reactivity in organic photochemistry. The premise is that Baird’s rule, i.e., the reversal of
electron-counting rules for aromaticity and antiaromaticity in the ground and lowest excited-states of organic
compounds, underlies many photochemical reactions essential to biology and biological applications. Some
examples include light-induced bond twisting, photoheterolysis, electron transfer reactions, and proton-coupled
electron transfer reactions. The innovation is that linking reactivity to the structural features of aromaticity and
antiaromaticity may provide important chemical insights for designing new and useful reactions. Our research
involves the use of a variety of computational quantum chemical tools, including time-dependent density
functional theory (TD-DFT) and complete active space self-consistent field (CASSCF) methods. A five-year
goal is to significantly demonstrate the usefulness of Baird’s rule in many areas of organic photochemistry. An
overall vision of my research program is to prepare and foster a next generation of computational organic
chemists and to translate theoretical insights into experimental opportunities for biological and biomedical
research.

Public health relevance
Project Narrative This is a computational organic chemistry proposal. Three research directions are planned: 1) to develop photosynthetic strategies to access and harness the reactivity of transient organic compounds, 2) to establish a structure-reactivity relationship for designing efficient photocages, and 3) to understand how the rates of photoinduced electron transfer reactions might be connected to molecular structure. An underlying goal is to exploit the concepts of excited-state aromaticity and antiaromaticity for designing structure and reactivity in organic photochemistry for biological and biomedical applications.